Subgroup delineation in genetic epilepsies and developmental brain disorders

PROJECT SUMMARY
Over the last decade, there has been an exponential increase in identified genetic causes of neurodevelopmental
disorders and epilepsy. With more than 100 genes identified, understanding how phenotypes relate to specific
genetic variants is critical given the clinical complexity of developmental brain disorders. Given that treatment
and prognosis is dependent on understanding genotype-phenotype correlations, there is a critical need to better
assess clinical features in genetic epilepsies. However, phenotyping is a time-consuming, manual task with
limited throughput. To overcome this bottleneck, we have developed a novel approach, based on the Human
Phenotype Ontology (HPO) to capture and analyze longitudinal phenotypic data. In our preliminary data for
STXBP1- and SCN8A-related disorders, which we have reconstructed for >550 patient months, we identified
unique natural histories, outcomes, and distinct response patterns to specific treatment strategies. Natural history
and treatment response in pediatric epilepsies are deeply intertwined and often difficult to disentangle.
Accordingly, a comprehensive assessment of genetic epilepsies needs to account for two factors, subgroups
with common clinical trajectories as well as gene-specific treatment responses. Our suggested project therefore
has two aims. First, we plan to detect relevant subgroups in genetic epilepsies based on longitudinal clinical data
(Aim #1). We will reconstruct longitudinal trajectories and outcomes in the 15 most common genetic epilepsies
with 50-75 individuals per gene to delineate longitudinal seizure burden, seizures types, and developmental
milestones. Based on this, we will then identify subgroups defined by clinical features and global clinical
resemblance, as well as variant and gene groups. In addition (Aim #2), we will identify specific treatment
responses in genetic epilepsies using standardized phenotypes. We will combine reconstructed natural history
with treatment data to compare reduction in seizure frequencies and effect on maintaining seizure freedom
across >20 treatment strategies with the goal to identify the most effective treatment strategy when adjusting for
age and seizure type. Finally, we will also compare medication response across major variant classes and across
all genetic etiologies combined. Our team has previously pioneered computational phenotype analysis in the
epilepsies, positioning us uniquely to address these questions. Our analysis, mapping longitudinal clinical data
to a harmonized format will provide unprecedented granularity in deciphering the trajectory of genetic epilepsies,
informing clinical practice in these conditions. We hope that these results will provide a template for the analysis
of the limited clinical data in rare diseases in order to maximize treatment-relevant information, especially in
conditions with complex, longitudinal disease histories.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as more precise measurement of clinical data in genetic epilepsies and neurodevelopmental disorders is ultimately expected to translate into improved diagnostics, allowing for greater personalized treatment choices. Thus, the proposed research is relevant to the purpose of the RFA and mission of the NINDS by providing a dedicated program to delineate subgroups of epilepsies for better stratification of current and future treatments, thereby reducing the burden of neurological disease.